Combinatorial approach to restore breathing after spinal cord injury

PROJECT SUMMARY / ABSTRACT
More than half of human spinal cord injury (SCI) cases occur at the cervical level, resulting in permanent
respiratory deficits for which there is no treatment. Injury-induced axon growth of spared respiratory pathways is
a form of endogenous neural plasticity that can be harnessed to improve breathing. However, experimental
strategies to promote respiratory axon growth are lacking, and the few existing approaches have translational
limitations. Without expanding the repertoire of molecular and/or cellular interventions to enhance axonal
plasticity of the respiratory network following injury, developing treatment to restore breathing will be unlikely.
The objectives of this proposal are: first, to determine if endogenous astrocytes can be reprogrammed to
enhance structural plasticity of the respiratory system to improve breathing after SCI; and second, based on
evidence that coupling axon growth-promoting strategy with rehabilitative training can further augment functional
recovery, assess combinatorial effects of astrocyte reprogramming and respiratory training on recovery of
breathing after SCI. The central hypothesis is that post-injury targeting of astrocytes, combined with respiratory
training, will synergistically improve breathing after SCI. This hypothesis will be tested by pursuing two aims: 1)
determine the effects of pre-injury astrocyte manipulation alone, or in combination with respiratory training, on
structural and functional plasticity of the respiratory system; and 2) assess post-injury and location-specific
effects of astrocyte manipulation alone, or in combination with respiratory training, on respiratory plasticity. The
rationale for this proposal is that it will inform on the therapeutic potential of reprogramming endogenous
astrocytes to promote axonal plasticity of the respiratory system, which may be further harnessed by
rehabilitative training to maximize recovery of breathing after SCI.

Public health relevance
Project Narrative Public Relevance: Nearly 300,000 individuals in the United States have a spinal cord injury and close to 60% are at the cervical level. As a result, respiratory motor insufficiency is a major concern and necessitates the need for a mechanical ventilator in order to breathe and survive. This grant application explores a novel combinatorial approach to restore breathing, by promoting axon growth of respiratory pathways and applying respiratory training.